National Hispanic Science Network on Drug Abuse (NHSN) 2024 Conference Administrative Supplement

2024 NHSN Conference Administrative Supplement Abstract
The purpose of this proposal is to request funding available through an administrative supplement for the National
Hispanic Science Network (NHSN) Annual Conference grant (R13 DA026647). The NHSN is dedicated to
improving health equity of Hispanics by increasing the amount, quality, and dissemination of interdisciplinary
translational research and fostering the development, advancement, and promotion of future Hispanic scientists
and leaders. The NHSN conference assembles members of the global research community focused on different
aspects of substance use disorder including epidemiology, toxicology, environmental health, intervention
science, psychology, sociology, health policy, and neurobiology as it pertains to Hispanic populations. The NHSN
conference is unique in that it serves as a forum for transdisciplinary scientific discourse spanning from basic
neuroscience to implementation science and policy. The NHSN conference serves as a venue for mentoring,
networking, and professional development of scientists underrepresented in their respective disciplines. The
2024 conference will serve as a unique venue for transdisciplinary and interprofessional scientific discussions
on strategies towards minimizing the impact of substance use disorders and their comorbidities on health
disparities in Hispanics and other underrepresented minorities. In addition, the conference will feature a session
dedicated to women’s health. We will continue to foster recruitment, retention, development, and advancement
of Hispanic scientists to promote future leaders in substance use disorder research and related areas. The
conference is an opportunity for trainees of diverse gender, ethnicity, discipline, and geographic location to come
together and participate in a multidisciplinary scientific meeting, establish peer support groups, and develop
professional relationships that provide venues for innovative developments in the field.

Public health relevance
2024 NHSN Conference Administrative Supplement Project Narrative Hispanics constitute the largest racial/ethnic underrepresented group in the United States and are disproportionately impacted by substance use disorder, such as drug types, alcohol, tobacco, and more. There is a pressing need to study the biological, individual, familial, community, legal, and contextual factors that differentially affect substance use, its consequences, and the use of treatment services in Hispanic populations through interdisciplinary and translational approaches. The proposed annual NHSN conference will continue to serve as the premier venue for transdisciplinary, interdisciplinary, and interprofessional scientific discussions on strategies to minimize the impact of substance use disorder on health disparities in Hispanics and other underrepresented groups.